Enantioselective desymmetrizing hydroamination to synthesize complex all-carbon quaternary stereocenter containing saturated heterocyclic structures

Project Summary/Abstract
Heterocyclic rings and tetrahedral carbons are common components of successful small molecule drugs.
The polarity and hydrogen bonding capability of heterocyclic rings promotes solubility in aqueous solutions
and provides opportunities for critical intermolecular force interactions with protein targets, thereby
promoting drug-protein binding affinity. Tetrahedral carbons in drugs create selective interactions with
protein targets thereby minimizing unwanted side effects due to interactions with non-target proteins or
other biomolecules. Tetrahedral carbons are also believed to facilitate small molecule dissolution because
more three-dimensional molecules pack less efficiently into the solid phase and therefore more readily
separate. All-carbon quaternary carbons are one of the most difficult types of tetrahedral carbons and are
common in bioactive molecules, especially those found in nature. In fact, structure searches of fused
heterocyclic rings with quaternary carbons at the bridgehead are found by the thousands in bioactive
molecules, yet there is no general synthetic tool to enantioselectively construct these molecules.
The current proposal describes an efficient synthetic tool to enantioselectively construct fused heterocyclic
compounds with bridgehead quaternary carbons from inexpensive benzoic acid derivatives in four or five
steps. The method generates symmetrical cyclohexadiene structures from Birch reduction-alkylation
reactions of benzoic acid derivatives and then desymmetrizes them through enantioselective alkene
hydroamination reactions. The proposal will explore the use of chiral copper catalysts to facilitate the
enantioselective desymmetrizing hydroamination reaction. Copper has the advantage of both low cost and
being environmentally benign. The research would build on the enantioselective desymmetrizing Mizoroki-
Heck reactions that we have previously reported for both palladium and nickel chiral catalysts. It also seeks
to extend the impressive copper-catalyzed hydroamination work by other researchers to enantioselective
desymmetrizing reactions.
Critical to the reaction development will be the use of computational chemistry to model the key amino-
cupration step, which is the likely rate and enantioselectivity determining step based on literature precedent.
Leveraging our experience with understanding the basis of enantioselectivity in the analogous 1,2-insertion
of the desymmetrizing Ni-catalyzed Mizoroki-Heck reaction, we will accelerate the search for optimal
chiral ligands by modeling the key amino-cupration step. Most importantly, the project will provide three
undergraduate students and one graduate student with exposure to and training in contemporary synthetic
chemistry reaction development to address an important deficiency in the armamentarium of synthetic tools
for complex molecule synthesis in the 21st century.

Public health relevance
Project Narrative Heterocyclic rings and tetrahedral carbons populate successful drugs. Methods to efficiently and selectively synthesize heterocyclic rings with tetrahedral carbons from inexpensive starting materials are proposed. The envisioned synthetic tools have the potential to accelerate the development of new and improved small molecule drug therapies.